NATIONAL CHILDREN'S STUDY

The purpose of this contract is to provide the continued IMS activities including supplies and services provided by Northwestern University (NU) IMS Hub via the NU Bioinformatics Core (NUBIC). The NU Hub currently supports ten NCS Vanguard Locations and will maintain the capacity to accommodate additional Locations as needed but not to exceed 20.